Frailty related risk: Poor physiologic reserve during and after valve replacement

DESCRIPTION (provided by applicant): The proposed K23 Career Development Award will enable Dr. Philip Green to establish an independent career with expertise in conducting research in interventional geriatric cardiology. Dr. Green is a clinical interventional cardiologis whose long-term goal is to optimize outcomes in older adult patients who receive invasive procedures to treat heart disease. However, further research training is required to accomplish this goal. Dr. Green's prior work has led the way in demonstrating that frailty is an important ris factor that compliments traditional cardiovascular risk assessment and that frailty increases the risk for adverse events after valve replacement in older adults with aortic stenosis.1, 2 The primary objective of this K23 research training program is to identify mechanisms underlying frailty related risk in order to lay the groundwork for future studies designed to test interventios to target those mechanisms and reduce the risk of adverse outcomes in older adults with aortic stenosis. We hypothesize that decreased physiologic reserve manifested in the operating room during valve replacement and during recovery after valve replacement mediates frailty related risk of adverse outcomes. To test this hypothesis this proposal outlines two separate but related studies. Study 1 will analyze continuously recorded physiologic data collected during the valve replacement procedure to evaluate the impact of impaired physiologic reserve during the procedure on complications immediately after valve replacement. Study 2 will use accelerometers to measure activity before and for 6 months after valve replacement to analyze the dynamics of physical activity recovery as a mediator of frailty related decreased quality of life after valve replacement. To conduct this research training, Dr. Green has assembled a multidisciplinary team of mentors to provide training in: (1) geriatric cardiovascular research methods; (2) quantitative methods for evaluating high density repeated measures datasets; (3) biostatistical methods for evaluating complex constructs (mediation); and (4) ethical research conduct and research dissemination. He has also enrolled in and completed courses toward a Master's Degree in Biostatistics Clinical Research Methods program at the Columbia Mailman School of Public Health. This area of research addresses an unmet public health need in that it aims to identify a novel pathway to improve outcomes in older adults with aortic stenosis who receive valve replacement. Aortic stenosis is a common and growing problem among older adults and can only be cured with valve replacement. Advances in transcatheter aortic valve replacement (TAVR) and surgical aortic valve replacement have made valve replacement available to high risk and frail older adults.3 Therefore efforts to improve outcomes in this population should be seen as a high priority. This K23 proposal will position Dr. Green to accomplish his goals of identifying novel targets for optimizing outcomes in the frail elderly with heart disease and facilitate his development into an independent investigator in the field of geriatric interventional cardiology.

Public health relevance
PUBLIC HEALTH RELEVANCE: We will conduct observational studies to test the hypothesis that decreased physiologic reserve is a mechanism that explains adverse outcomes related to frailty. The prevalence of significant aortic stenosis in patients aged 70 to 80 years is estimated to be 2% and as the population ages, its prevalence will increase. Advances in endovascular treatments for valvular disease are addressing the marked undertreatment of aortic stenosis in the frail elderly. Accordingly, improving outcomes in the frail elderly who receive valve replacement or other cardiac interventions is a public health priority. This research will identify novel targets to improve outcomes in older adults who receive cardiac procedures.